Iowa Cochlear Implant Clinical Research Center - VIII

Program Director/Principal Investigator (Last, First, Middle): Gantz, Bruce J.
PROJECT SUMMARY – CORE B
Core B's primary responsibilities are to accrue a subject population; provide the clinical service for these
subjects; maintain a cochlear implant (CI) research registry; monitor postoperative residual hearing; and obtain
audiologic and speech perception outcome measures that will be used in the research projects. Core B will
also provide the technical and statistical support for all investigators. The four research projects are highly
interdependent and interrelated. Each project depends on data generated by the others to address their
specific aims, using similar subject populations to address the Iowa Cochlear Implant Clinical Research
Center's (ICICRC) overall goals.
Described here are (1) extensive preoperative evaluations required for subject accrual; (2) specific
populations to be studied; (3) CIs to be used; (4) basic audiologic and speech perception outcome measures of
performance that will be obtained from subjects; and (5) the time-line of subject involvement. The overall
statistical design, data management and technical support are also discussed. The individual projects describe
the specific research questions and how each project is interactive and dependent on the others.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Gantz, Bruce J. NARRATIVE See Overview for project narrative for the project’s relevance to public health.